Evaluation of the effect of exogenous AMH on ovarian function and fertility

Project Summary/Abstract:
AMH functions as a master regulator of ovarian function, capable of inhibiting primordial follicle activation,
suppressing early preantral follicle growth, modulating antral follicle maturation, and producing contraception
when given at supraphysiological doses in mice, rats, and cats. Given these potent and pleiotropic effects, and
its distinct mechanism of action uniquely affecting follicles before they become responsive to gonadotropins and
sex steroids, AMH has shown substantial promise as a treatment for various indications in women's health.
Indeed, treatment with AMH may be used for contraception, synchronization of follicles for stimulation, and
protection from accelerated ovarian aging in chemotherapy-induced ovarian failure models. Yet most of what we
know about the role of AMH in the ovary is derived from rodent models whose reproductive physiology is
dissimilar to humans, being poly-ovulatory with shorter cycles, and no menses. To better understand the function
of AMH in humans, we propose to use non-human primates (NHPs) as a model.
Our long-term goal is to understand how AMH affects ovarian function in primates, and if supraphysiological
levels are safe, and have beneficial effects on fertility. These discoveries could expand our understanding of this
hormone in mono-ovulatory species and facilitate the development of novel treatments based on AMH for
humans. We hypothesize that supraphysiological AMH can induce contraception without disrupting estradiol
homeostasis, reduce the rate of attrition of the ovarian reserve and ovarian aging, and when given at sub-
contraceptive levels improve oocyte and embryo quality. Our rationale, for testing these hypotheses in NHP is
that AMH function is highly context- and dose-dependent and that the use of these models is necessary to better
understand the biology of AMH, and the risks and opportunities of AMH as a treatment, in humans. Our specific
aims will be to test the following hypotheses: 1) that AMH prevents ovulation but maintains reproductive
hormones and cyclicity and is safe when administered chronically at supraphysiological doses; 2) that AMH
modulates follicle dynamics and reduces the rate of activation of primordial follicles by affecting follicle maturation
and development thereby reducing ovarian aging; and 3) that chronic AMH treatment does not adversely affect
oocyte or embryo quality, and in some context may even improve oocyte quality, and pre-implantation embryo
development.
The proposed studies would represent a significant contribution to our understanding of the mechanisms of
action of AMH in female fertility, with the potential to produce proof of concept of applications with significant
clinical impact. Furthermore, it will provide novel insights into the gonadotropin- and sex-steroid-independent
mechanisms of regulation of ovulation and ovarian aging, representing some of the greatest remaining mysteries
of reproductive biology. These studies are highly innovative, by providing for the first time a comprehensive
assessment of how AMH modulates ovarian biology and reproductive function in primates.

Public health relevance
PROJECT NARRATIVE Anti-Müllerian hormone is a master regulator of ovarian function with many potential applications to women's health, yet little is known about its function in the human ovary. This proposal seeks to evaluate the effect of AMH on the rhesus ovary using gene therapy to induce long-term supraphysiological exposure. This model, which most closely resembles humans, will allow us to make significant contributions to our understanding of this hormone in women's health, and determine if AMH treatment is safe, can produce contraception, modulate reproductive hormones, affect ovarian aging, and potentially improve egg and embryo quality.